Extending the Capabilities and Reach of EMERSE in Support of Cancer Research

PROJECT SUMMARY
The free text notes in electronic health records (EHRs) contain details vital to cancer research that often are
found nowhere else in the EHR. Such details include social and behavioral determinants of health, family
histories, cancer staging, tumor markers, disease progression, response to treatment, overall outcomes, and
more. Utilizing the free text (also called unstructured data) can be challenging, and researchers need tools to
help them leverage those data in a meaningful way. The electronic medical record search engine (EMERSE)
has been in operation, and under continuous development, for 17 years and was designed to help cancer
researchers meaningfully use unstructured EHR data. EMERSE started as simple information retrieval system
but has since gained many features for supporting clinical research. It is distinguished from other text-processing
research tools, in part, by its ease of use and other enterprise software features such as maintaining audit logs
and providing administrator functions. With the support of an ITCR grant that is nearing completion, EMERSE
has grown from a tool used at only one site (University of Michigan) to one that is running, or being implemented,
at multiple cancer centers and other academic research institutions across the country. EMERSE also now
supports the capability of searching across a network of instances to securely obtain obfuscated patient counts
at other sites, which can be valuable for identifying rare cancer cohorts. The innovations in this proposal include:
(1) Building new functionality into EMERSE to expand its research capabilities such as timeline data
visualizations, self-service data extraction workflows from templated notes, support for optical character
recognition (OCR), and integration with other ITCR tools such as DeepPhe through an application programming
interface (API); (2) Incorporating natural language processing (NLP) into EMERSE including named entity
recognition (mapped to the Unified Medical Language System, UMLS), negation (e.g., “patient denies pain”),
uncertainty (e.g., “possibility of recurrence”), and experiencer (e.g, “breast cancer in her mother”); (3) Expanding
the EMERSE network in breadth, capability, security, and trust by partnering with external sites to collectively
develop a consensus and a viable approach for broadly enabling this novel network technology; and (4)
Continuing to evaluate EMERSE with a focus on networking, security, and scientific outcomes by conducting
additional user-centered studies to develop a deeper understanding of how EMERSE is being, or could be, used
with a goal of continuous improvement. The EMERSE team routinely receives feedback from users and site
administrators and the proposed work is highly responsive to our growing user base and will enable research
that is currently impractical, if not impossible, for many researchers to accomplish. The enhancements and
knowledge gained from this effort will make EMERSE even more powerful and capable of supporting a wide
range of clinical and translational cancer research for a growing user base across the nation.

Public health relevance
PROJECT NARRATIVE Unstructured (free-text) clinical notes in electronic health record (EHR) systems contain valuable phenotypic, genomic, and other data needed to support cancer research ranging from identification of rare cancer cohorts to data abstraction. These notes remain underutilized, in part, because of the complexity of accessing and extracting details from the unstructured data. EMERSE (The Electronic Medical Record Search Engine), an easy-to-use, mature, information retrieval software system that is being used or implemented at research institutions across the nation, simplifies this process. The aims of this proposal are to develop novel, valuable, user-prioritized features to extend the power and reach of EMERSE, including incorporating Natural Language Processing (NLP) capabilities.